PHS 2018-02 Omnibus Solicitation of the NIH, CDC, and FDA for Small Business Innovation Research Gra

Project Summary/Abstract This is the phase II application of a NIDA funded SBIR grant titled “Demand Reduction Smart Tool for Analysis and Research (STAR)” (NIDA Grant 1R43DA041030-01A1). The goal of Phase II is to develop a commercial grade Self-Service Visual Analysis (SSVA) tool based on Phase I STAR Prototype empowering decision makers and managers in drug demand reduction field to make data-driven decisions in managing the current public health crisis: Opioid Overdose Death Pandemic. Building on STAR Prototype, phase II project will focus on achieving 4 specific aims: Specific Aim 1: Expand current data sets collection to cover all aspects of DRIF with a special focus on opioid overdose death pandemic. Specific Aim 2: Enhance STAR’s predictive and prescriptive analytic capabilities to make it an early-warning and intervention planning tool for managing opioid overdose death pandemic. Specific Aim 3: Develop STAR Prototype into a reliable commercial grade analytic service for use by multi-level users at scale. Specific Aim 4: Conduct a pilot testing of STAR service with potential customers from federal, state, and local levels in preparation for a full scale commercialization in Phase III.

Public health relevance
Project Narrative This is phase II application of a NIDA funded SBIR grant titled “Demand Reduction Smart Tool for Analysis and Research (STAR)” (NIDA Grant 1R43DA041030-01A1). The goal is to develop a commercial grade Self-Service Visual Analysis (SSVA) tool based on Phase I STAR Prototype empowering decision makers and managers to make data-driven decisions in managing the current public health crisis: Opioid Overdose Death Pandemic. While the development of Demand Reduction Information Framework (DRIF) by international experts in 2012 lays the foundation for data-driven demand reduction policy, program, and practice, decision makers still face major challenges in turning complex and often fragmented data into actionable intelligences. First, it is difficult to determine the quality of data; “garbage in, garbage out.” Second, no matter how feature-rich the visual presentation software, the information is not useful without business context. Third, there is a dependency on data analysts and IT personnel to unlock insights from available data. The STAR visual analytic dashboard service will address all three challenges by empowering decision makers and managers to visually analyze the key indicators defined by DRIF in real time to contextualize core indicators that are critical to the design of public strategies, policies, and programs and to inform policy and program managers’ decision-making.